UNZA-Vanderbilt Training Partnership for HIV-NCD Research (UVP-2)

PROJECT ABSTRACT
The goals of the parent project UNZA-Vanderbilt Training Partnership for HIV-NCD Research (UVP-2)
are to build the University of Zambia (UNZA)’s research capacity by continuing our “sandwich” model of PhD
training. We have used a similar model to develop a postdoctoral training program to further strengthen the
pipeline of independent UNZA scientists. With this supplement, we will introduce new training mechanisms
and support structures at UNZA and Mulungushi University (MU), through the Zambia Leadership in
Research Program (ZAMLead). ZAMLead will enhance and expand prior research training in Zambia by (1)
building critical competencies in leadership and management, strategic partnerships, and policy and
advocacy for diverse trainees (students, post-doctoral fellows, junior faculty) with different areas of scientific
expertise, and (2) enhancing diverse perspectives in the UVP2 parent grant by including new institutional
partners who are based in underserved, geographically different, and/or rural or semi-urban areas and
expand much needed support for future leaders in research at those institutions.
The current supplement request responds to NIH’s Notice of Special Interest (NOSI) NOT-TW-24-006
Opportunity Pathways in Global Health Research and Training. There is a pressing need for additional
capacity building for research scientists in Zambia, particularly for under-represented and diverse
populations. Leaders at UNZA and the Vanderbilt Institute for Global Health (VIGH) have collaborated since
1998 to train Zambian and American scientists to build institutional capacity and develop researcher skills
across numerous grant-funded training programs. However, additional innovative ways to support
researchers’ career development and diverse trainees will be crucial to meet the need of building an inclusive
national workforce in research in Zambia. After conducting a needs assessment, we propose to develop a
2-month pilot training program in research leadership that leverages past skill-building workshops for
Zambian research leaders. This program will include targeted new trainings and expanded structured
mentorship opportunities to meet the unique needs of diverse research leaders in various higher education
institutions in Zambia. To accomplish these goals, we aim to (1) Develop a new research leadership training
program for diverse Zambian researchers in the country utilizing Community Advisory Boards to bring diverse
perspectives to the research enterprise; (2) Implement a pilot ZAMLead Program to train 20 fellows in
leadership and management, strategic partnerships, and policy and advocacy; (3) Use an iterative evaluation
model to optimize the sustainability of the training program as a component for facuty and trainee
development and (4) Create a strategic plan for scaling the program to other universities across Zambia.
Consistent with the NIH Supplement objectives, the overall goal of this initiative is to bolster professional
competencies of investigators in Zambia and the region so that they are well-equipped to initiate and lead
research at their local institutions.

Public health relevance
Millions of persons with HIV in sub-Saharan Africa are now surviving for decades on treatment but are devel- oping chronic non-communicable disease complications that require new science and new directions in pre- vention, detection, and treatment. The University of Zambia (UNZA)-Vanderbilt HIV Research Training Partner- ship (UVP) has been extremely successful, achieving all its aims including supporting 11 UNZA PhD students, evaluating and facilitating a new structure for the UNZA PhD Program, and hosting two UNZA Visiting Faculty Scholars at Vanderbilt. We will deepen and extend the impact of UVP in catalyzing UNZA's research capacity by shifting the grant's primary leadership to UNZA, training five UNZA PhD students and four postdoctoral sci- entists, implementating UNZA's new postdoctoral fellowship program, adding two South-South partnerships with the University of the Witwatersrand and the Consortium for Advanced Research Training in Africa (CARTA), and establishing a Biostatistics Support Core service at UNZA.